Research Examining Factors Associated with the Opioid Crisis among Underserved African Americans (REFOCUS)

ABSTRACT
Opioid-related overdose rates among African Americans have increased exponentially. Given African
American opioid users have the lowest treatment completion rates when compared to other races/ethnicities
there is increased risk for mortality and morbidity. As a result, there is a dire need to better understand this
fatal epidemic among this historically underserved group. Using the theory of Subcultural Evolution and Drug
Use which suggests cultural and generational influences are linked to drug use patterns and risks among
African Americans, the Research Examining Factors Associated with the Opioid Crisis among Underserved
African Americans (REFOCUS) project will employ a within-racial group, mixed-methods design among African
American adults in the community. The overall objective is to better understand the complex structural, social,
and cultural factors that differentially influence NMPOU, other nonmedical prescription drug use and treatment
service use among African Americans. Ultimately, our goal is to gather data that will inform culturally-tailored
interventions to reduce NMPOU and better facilitate initiation and completion of treatment. The REFOCUS
project has three aims: 1) To understand cultural and generational characteristics associated with
NMPOU, other NMPDU, illicit drug use and treatment service use. We will conduct in-depth interviews with
approximately 40 African American nonmedical prescription opioid users stratified by gender and age to
understand NMPOU across the lifespan within the context of lived experience. Using thematic analysis, data
will be gathered to culturally-tailor the survey. 2) To assess structural, social and cultural patterns of
NMPOU, other NMPDU, illicit drug use and treatment service use among 800 (400 = male and 400 =
female) African American NMPO users. We will conduct cross-sectional face-to-face culturally-informed
surveys (modified by information obtained in Aim 1) and drug testing using targeted recruitment and stratified
sampling by age and gender. 3) To pretest messaging generated from initial findings that will inform
targeted interventions specific to African American nonmedical prescription opioid users. We will
conduct in-depth, semi-structured interviews and using health communication techniques, we will develop a
library of cultural, gender, and generational specific messages related to decreasing NMPOU and increasing
treatment engagement and retention. We will test these messages that will be constructed from Aim 1 and Aim
2 data with approximately 40 African American nonmedical prescription opioid users stratified by gender and
age. This pretesting task will prepare us to conduct a fully powered RCT as the next step in our research.
This underrepresented new investigator led project directly aligns with the PAR and NIDA’s priority focus
area of “addressing real-world complexities”. As this high-impact project focuses on a marginalized group
underrepresented in opioid use research and it has the potential to yield insights on ways to culturally-tailor
future interventions for African Americans.

Public health relevance
PROJECT NARRATIVE The REFOCUS project-“Research Examining Factors Associated with the Opioid Crisis among Underserved African Americans” has significant public health implications by examining how structural, social and cultural factors influence nonmedical prescription opioid use (NMPOU) and treatment service use among African Americans across the adult lifespan. Overdose rates have risen exponentially among African Americans but this group has received much less attention. The REFOCUS project will generate data directly applicable to culturally-tailor interventions targeting African American opioid users in order to reduce NMPOU and improve treatment outcomes.